Specificity of Plasmodium falciparum protein export

The malaria parasite Plasmodium falciparum exports several hundred
proteins into its host cell to modulate nutrient uptake, infected RBC biophysical
properties, adherence to vascular endothelium and host immune response. These
exported protein effectors are synthesized in the parasite ER, traverse the
secretory system and are then translocated from the parasitophorous vacuole (PV)
into the host RBC. Most have a protein export element (PEXEL) that is essential
for the export process but is cleaved co-translationally by the aspartic protease
plasmepsin V. How the processed protein is recognized for export is not at all clear.
Certain mutations in the mature N-terminus of PEXEL-containing reporter
constructs can prevent export, but changing the mature N-terminus to all alanines
does not impair export. We hypothesize that export is the default pathway for
secretory proteins and that specific mutations block export or promote PV retention.
We posit that these mutations dictate recognition by a chaperone. To establish this
model, we must identify the chaperone(s) that confer specificity.
To address these questions, Aim 1 will focus on the protein machinery that
mediates export specificity. Export-destined and PV retained proteins will be pulled
down from the PV and from the ER. Comparative proteomic analysis will be
employed to identify key components of the export pathway. Proximity biotinylation
will comprise a second approach to this analysis. Candidate interacting proteins
will be validated in reciprocal pulldowns. This will pave the way for future reverse
genetic and biochemical assessments. We anticipate that the proposed studies
will yield great insight into the mechanism of protein export that is so important to
the pathogenesis of malaria. We hope that this work will point the way to new
therapies for this devastating disease.

Public health relevance
Malaria afflicts several hundred million and kills more than 600,000 people each year, mostly children in Sub-Saharan Africa. The deadly malaria parasite Plasmodium falciparum causes disease by exporting hundreds of proteins into its host red blood cell. This proposal aims to understand how these proteins are recognized by the parasite machinery for export. By understanding the molecular basis of protein export, we will be able to identify targets for development of new therapies to treat or prevent malaria.